PROTEIN SEQUENCE ANALYSES

During the past year, the amino acid sequence of over 220 proteins and peptides has been determined by automated protein sequence analyses. In the case of several malaria proteins and a schistosome protein, the facility has purified tryptic peptides for sequence analysis by reverse phase microbore HPLC separation. Studies in which these analyses have had a major impact are listed below: (1) the characterization and identification of the putative gag- pol protease and gag encoded gene products of human immunodeficiency virus (HIV) (Laboratory of Molecular Microbiology); (2) the characterization of human pro-gastrin- release peptides expressed in baculovirus (Navy Medical Oncology Branch,778 NCI); (3) the identification of previously unidenitifed vaccinia virus encoded proteins (Laboratory of Viral Diseases); (4) the characterization of high-efficiency purified interleukin 4 (Laboratory of Immunology); (5) the structure of T-cell activating protein (TAP) and related Ly-6 encoded molecules (Harvard Medical School); (6) the identification of a chimeric MHC class II/class I protein expressed on the cell surface (Laboratory of Immunology); (7) protein sequence determinations which allowed the development of oligonucleotide probes for the cloning of PFs25 that is expressed on zygotes an ookinetics of P. falciparum (Laboratory of Parasitic Disease); (8) the identification of hamster MHC class I antigens (Laboratory of Immunopathology; (9) analysis of the BCDF (Il-6) receptor (Laboratory of Immunoregulation); (10) identification of Dengue virus pre-matrix structural protein (Laboratory of Infectious Disease).